Coordination Section

PROJECT SUMMARY COORDINATION CORE
The Jackson Laboratory (JAX) Center for Precision Genetics (JCPG) brings together a multi-disciplinary team
including geneticists, genetics technology experts, quantitative and computational biologists, clinical experts,
and experienced resource managers. The purpose of the Coordination Core is to ensure productive interactions
among all participants and to oversee and facilitate all administrative and scientific functions of the JCPG,
including the review of new external disease nominations. Under the direction of the JCPG PD/PIs and the
Program Manager, and with support from dedicated staff, the Coordination Core executes its duties with the
guidance of a Steering Committee (SC) and an External Advisory Board (EAB). Specific responsibilities include:
1) scientific oversight and leadership of the JCPG; 2) execution of the outreach plan to recruit nominations for
model generation from the medical/scientific community; 3) fiscal and research resource management and
allocation; 4) promotion of free and dynamic scientific exchange by facilitating interactions among JCPG
personnel, the EAB, external stakeholders and collaborators; and 5) the evaluation of projects, cores and the
JCPG in line with the mission and milestones of our proposed Center and NIH goals. The Coordination Core
was the critical organizing force for the JCPG during the current funding phase, as demonstrated through key
activities including assembling SC and EAB members; establishing, tracking and evaluating key program metrics
of success; ensuring timely and effective communications across JCPG stakeholders; coordinating collaborative
meetings with diverse teams of researchers, clinicians, and foundations; refining processes to maximize access
to JAX’s wealth of services and expertise; overseeing the intake and review of new nominations; and broadening
community awareness of and engagement with the Center. The Core will continue to perform these and related
activities to ensure the Center’s continued impact and success in the next funding period. The Coordination Core
will achieve its goals through three Specific Aims: 1) Strengthen integration and function of JCPG activities
through strong administrative and technical oversight; 2) Promote center productivity and scientific synergy
through effective communication and outreach; and 3) Refine and prioritize variant nominations for the center.